Administrative Core

PROJECT SUMMARY / ABSTRACT
Lung recipients suffer from shorter life spans and higher rejection rates when compared to other solid organ
recipients. To further advance a program project dedicated to uncovering the mechanisms of lung transplant
rejection to facilitate the discovery of new therapeutic targets, an administrative core is proposed with three
specific aims: (1) Facilitate communication between the three projects and the Microsurgery Core, (2) report
financial resource utilization to enhance productivity, and (3) assemble a scientific advisory committee to
review scientific progress. The administrative core will consist of a core leader and an administrative lead.
The overall goal of the administrative core is to leverage the intellectual and financial resources of the
individual projects to maximize overall scientific productivity.